Multidisciplinary Rheumatology Training Program

ABSTRACT
The objective of the T32 Multidisciplinary Rheumatology Training Program at Johns Hopkins is to train and
grow a cadre of outstanding rheumatologists and scientists to become leaders across the biomedical research
enterprise, advancing knowledge and improving outcomes for those living with rheumatic disease. This goal is
directly aligned with the NIAMS mission to support training of basic and clinical scientists to conduct research
into the causes, treatment, and prevention of arthritis and musculoskeletal diseases. Over the past 20 years,
our program has demonstrated outstanding trainee achievement, in the areas of publications, appointment to
academic positions, acquisition of peer-reviewed funding, and leadership positions in national and international
organizations, including government and industry. In the current proposal we will pursue the following specific
aims to meet our goal: (1) Provide rigorous training in investigational methods applicable to clinical and basic
research; (2) Use clinical Centers of Excellence to access well-defined rheumatic disease patient populations;
(3) Provide access to outstanding resources, methodologic, and analytical expertise to facilitate research
success; (4) Engage trainees in high caliber collaborative research projects to address important questions
across the spectrum of rheumatic diseases under the supervision of multi-disciplinary, nationally-renowned
faculty; (5) Develop multi-layered, personalized mentorship teams for each trainee to foster successful
investigative careers; and (6) Assess program outcomes and modify to ensure maximal impact. We have
developed an outstanding infrastructure to support training and research that is grounded in disease-specific
Centers of Excellence, closely integrating clinical care and research. This is linked to a highly productive and
collaborative group of program faculty and mentors that incorporate multidisciplinary investigative teams to
explore novel areas of research and ensure project success. Our diverse program faculty represent the
breadth of interests and expertise across the clinical, translational, and basic science disciplines, and are
proven mentors in rheumatic diseases, immunology, molecular biology, genetics, cell biology, epidemiology,
and biostatistics supported by individual, collaborative, and institutional research grants. We have engaged
highly expert internal and external advisory committees to provide advice about the program's priorities,
systems, and directions. We use a matrix approach to develop multidisciplinary mentoring teams for trainees
around specific research projects. These projects are guided by individual development plans, formal course
work, and core conferences and include instruction on responsible conduct of research and ensure scientific
rigor and reproducibility. Postdoctoral trainees may pursue a Master’s degree in Health Sciences, Public
Health, Immunology, and Biomedical Engineering and additional coursework to further their investigative skills.
Our innovative and highly effective training program coupled with this T32 resource will foster the development
of the next generation of academic Rheumatology investigators and leaders.

Public health relevance
PROJECT NARRATIVE Autoimmune rheumatic diseases are a major cause of morbidity and mortality. Defining pathophysiologic mechanisms, recognizing disease phenotypes and trajectories, identifying risk factors, and directing interventional and prevention programs requires a cadre of well-trained investigators in rheumatic diseases. Our goal is to provide training to highly qualified individuals who will become the future leaders in academic rheumatology.